Mechanisms Underlying the Pathogenesis of Non-alcoholic Fatty Liver Disease

Project Summary
Project Summary: Non-alcoholic fatty liver disease (NAFLD) is one of the most common chronic liver diseases
worldwide. The pathogenic mechanism remains incompletely understood. Bile acids (BAs) are endocrine
hormones that are important for the biological processes. Dysregulation of BA metabolism may cause
cholestasis, liver cancer, NAFLD, etc. Activation of BA receptors FXR and TGR5 has been shown to protect
against NAFLD in mice and clinical trials. Transmembrane protein 141 (TMEM141) belongs to the TMEM protein
family that consists of proteins of mostly unknown functions. So far, nothing is known about the biological
functions of TMEM141. In this project, we plan to investigate the role of hepatic TMEM141 in the pathogenesis
of NAFLD. We will investigate whether and how hepatic TMEM141 regulates the development of NAFLD and
bile acid metabolism, and how hepatic TMEM141 expression is regulated in NAFLD. We will use a number of
genetically modified mice and a complementary approach to accomplish our goals.

Public health relevance
Project Narrative Relevance: NAFLD is one of the most common chronic liver diseases worldwide. Completion of the proposed studies will help determine the role of hepatic TMEM141 in regulating the pathogenesis of NAFLD, bile acid metabolism, and mitochondrial functions, and may lead to a new strategy for treatment of NAFLD. Thus, this project is highly relevant to human health.